Mechanisms of Human DNA Double-Strand Break Repair via Quantitative Single-Molecule Imaging

Project summary
Genetic instability and impaired DNA replication and repair are key contributors to the development of cancer
and severe human syndromes. This research program focuses on studies of the mechanisms of replication-fork
(RF) stability and DNA double-strand break (DSB) repair, two crucial aspects of genomic instability that can lead
to cancer, and associate with therapeutic response and other human disease. DSBs are the most dangerous
form of DNA damage, occurring due to normal cellular processes, exposure to ionizing radiation (IR), and
chemotherapy drugs. In mammalian cells, there are two primary pathways for repairing DSBs: non-homologous
end joining (NHEJ) and homologous recombination (HR), both of which play a vital role in maintaining genomic
stability. Despite the emergence of new and advanced cancer treatments, chemotherapy remains the standard-
of-care, yet it generally fails to address differential response and mechanisms of resistance that often occurs.
Patient-specific mutations in NHEJ and HR proteins are still the subject of intense study, and related factors are
being actively pursued as potential therapeutic targets. However, the specialized steps and processes affected
by these mutations remain unclear due to the limitations of standard biochemical and cellular methods in
measuring critical intermediates and functional features of these repair processes. We have limited
understanding regarding the toxicity of replication-fork lesions, the physical nature of molecular complexes during
DSB and fork repair, their spatial and temporal organization in the cell, and their regulation and interactions at
the chromatin level. Our research program aims to address these unknowns by defining key mechanistic steps
of human DNA repair using an array of single-molecule assays and methods that are accompanied by
contemporary cellular, biochemical and molecular biology approaches and tools. Combined, our studies will
address critical unanswered questions having enormous potential for advancing the field of DNA damage
research.

Public health relevance
PROJECT NARRATIVE The limitations in our understanding of DNA repair process and replication fork maintenance directly affect our approaches to the treatment of human diseases and cancers. This proposal is highly significant because it examines complex levels of human DNA repair that have relevance to aberrant DNA replication and repair in cancer and other human syndromes.